Induction of autophagy to enhance CAR-T cells in HIV cure approaches

ABSTRACT
Chimeric Antigen Receptor (CAR) T-cells have emerged as a promising immunotherapy in controlling
HIV-1 infection. However, CAR-T cells are also subject to immune dysfunction/exhaustion mediated by
persistent inflammation during chronic HIV infection. Strategies to prevent exhaustion/restore functions of anti-
HIV CAR-T cell are critical for ultimately achieving HIV functional cure. Our preliminary studies have showed
that autophagy induction can improve mitochondria function and promote CAR-T cell cytotoxic T lymphocyte
activity in vitro. Importantly, we found that induction of autophagy can prevent excessive IFN-I signaling and in
vivo treatment with autophagy inducer rapamycin in chronically HIV infected humanized mice can decrease
inflammation, restore exhausted anti-viral T cell function, and reduce viral loads. In addition, we found that
autophagy inducers such as rapamycin allow efficient HIV-1 latency reversal by PKC activator bryostatin-1
while reducing T cell activation associated immune toxicity. Therefore, we hypothesize that autophagy
induction can enhance ‘kick and kill’ HIV cure approaches by improving the survival, persistence and function
of anti-HIV CAR-T cells and facilitating effective and safe latency reversal by PKC modulators. We will utilize
our well-established humanized mouse model engineered with anti-HIV CD4CAR T cells to investigate the
therapeutic potentials of autophagy induction for HIV ‘kick and kill’ cure approaches. Our study will also provide
mechanistic insights into the development of immune exhaustion and autophagy’s regulation of CAR-T cell
function and will thus have a wide impact beyond HIV cure research.

Public health relevance
Project Narrative CAR T cells have emerged as a promising cell therapy to enhance anti-HIV immunity and eliminate latently HIV-infected cells when combined with HIV latency reversal in a ‘kick and kill’ cure approach. However, CAR T cells are affected by immune exhaustion and the most effective latency reversal agents are associated with drug side-effects, including generalized immune activation. Our proposed study aims to investigate the mechanisms and therapeutic potential of autophagy inducers to enhance anti-HIV CAR-T cell function while reducing the toxicity of latency reversal agents.